WEDGEWOOD EXPANSION DESIGN SUITES M & N

Suite H and K at 4600 Wedgwood Boulevard houses the NCI-F Central Repository. LBR has finalized leases with the landlord to secure the adjacent suites M and N and expand the Central Repository to these areas. The suites are currently office and warehouse space, so it is likely that the suites will be gutted and rebuilt. This project will expand the Wedgewood Central Repository operations currently in Suites H and K into the adjacent Suites M and Suite N. The scope of work will include the complete demo of all existing walls/ceilings/utilities, patch/paint, epoxy paint existing floors. New construction encompasses roof structural upgrade, installation of LN2 vacuum-jacketed piping, Automated Storage Retrieval System (ASRS) freezers, new electrical room and electrical distribution system, sprinkler system, stand-by generators, LN2 bulk tanks, receiving area, bathrooms, gown-in area, conference room, LAN room, custodial room, AHUs, exhaust and supply fans, air-cooled chillers, O2 monitoring system, security system, Rees scientific monitoring system, and access hallways to Suite K.